Patient and Family Member Reactions to Biomarker-Informed ADRD Diagnoses

Biomarkers of Alzheimer’s disease (AD) hold immense potential to impact clinical care of patients
with cognitive disorders. Yet, the potentially life-altering nature of learning one’s AD biomarker
status suggests that the burdens and benefits of such testing must be carefully balanced. Several
studies of the personal implications of such testing have found that disclosing AD biomarker
results does not cause clinical depression, anxiety, or suicidality. Most of this evidence has been
derived from samples comprised of highly educated, cognitively healthy, non-Hispanic Whites
who were scanned as part of a research protocol. There is pressing need to move beyond
investigations of the psychological safety of disclosing biomarker results to highly selected
research participants, to develop an understanding of the full range of burdens and benefits of
AD biomarker testing in real-world populations. The proposed study will leverage a considerable
opportunity to comprehensively characterize, within a large practice-based study of Medicare
beneficiaries, patient responses to diagnoses of cognitive disorders that include AD biomarker
testing. The New IDEAS study will enroll 7,000 Medicare beneficiaries at 350 sites throughout the
US and provide amyloid imaging. At least 4,000 participants will be Black/African American or
Hispanic/Latino, populations historically underrepresented in research on AD and related
disorders (ADRD). The proposed study has been vetted and approved by the New IDEAS
Research and Publications Committee. We will recruit 500 New IDEAS participants to enroll in a
6-month observational study to address the following Specific Aims. Aim 1. Quantify the range
and patterns of emotional response to a biomarker-informed cognitive diagnosis, and determine
which clinical or demographic factors are associated with specific responses. Aim 2.
Characterize the “value of knowing” one’s AD biomarker status among symptomatic patients and
their immediate family members. Aim 3. Identify the information and support needs of ethnically
and culturally diverse families receiving biomarker-informed cognitive diagnoses. Our overarching
hypothesis is that responses to biomarker-informed ADRD diagnoses are heterogeneous and
associated with distinct clinical and sociodemographic factors. This study will advance the field’s
understanding of real-world patient and family reactions to biomarker-informed ADRD diagnoses,
providing critical information for directing post-diagnostic resources to monitor and support those
most in need. Findings will inform best practices in the rapidly evolving state-of-the-art diagnostic
evaluation of cognitive impairment.

Public health relevance
This project will quantify the burdens and benefits of including tests of Alzheimer’s disease pathology in clinical evaluations of cognitive impairment, particularly within racially and ethnically diverse populations. This project will also advance our understanding of who is at risk for experiencing significant emotional distress after receiving a “biomarker-informed” cognitive diagnosis. A final goal of the project is to identify the unmet information and support needs of those who are at risk for such negative psychological reactions. Achieving these goals will help both research teams and clinical practitioners to better monitor and support persons undergoing biomarker tests for Alzheimer’s pathology as part of an evaluation for cognitive decline.